CP-CTNet Coordinating Center

Project Summary/Abstract
Cancer is the leading cause of morbidity and mortality in the US and in the world. One approach to reducing the
risk and burden of cancer is to use preventive agents and interventions that are effective and safe. According to
the Division of Cancer Prevention (DCP) at the National Cancer Institute (NCI), this requires the systematic
development of cancer preventive agents and interventions, with three critical components; i)
preclinical/toxicology studies for identification of agents through its Cancer Prevention Drug Development
Program (PREVENT), ii) early phase trials of identified agents and other promising interventions through the
Cancer Prevention Clinical Trials Network (CP-CTNet), and iii) late phase III trials of preventive agents and
interventions that have successfully passed through early phase trials in the National Community Oncology
Research Program (NCORP), in a three-legged approach.
As the second leg of this three-legged approach, CP-CTNet’s overall goal is to efficiently design and conduct
early phase clinical trials to assess the safety, tolerability, and cancer preventive potential of a variety of different
agents or interventions. Emphasis is on novel agents and interventions that target relevant pathways important
in carcinogenesis, to characterize the effects of these agents and interventions on their molecular targets,
immune function, and other biological events associated with cancer development (e.g., cell proliferation,
apoptosis, growth factor expression, oncogene expression, etc.) and correlate these effects with clinical
endpoints, to develop further scientific insights into the mechanism of cancer prevention by the agent or strategy
examined and to continue to develop novel potential markers as determinants of response and to facilitate
development and conduct of cross-network trials and to speed up preventive agent development. CP-CTNet
Sites will perform these early phase trials supported by DCP and the CP-CTNet Data Management, Auditing,
and Statistical Center (DMASC). These trials include phase 0 (micro-dosing), phase I (dose-finding), and phase
II (preliminary ef f icacy) clinical trials.
To support these early phase trials, which will be conducted by CP-CTNet Sites alone or as cross-network trials,
CP-CTNet DMASC will coordinate cross-network activities and provide expertise and resources in 1) centralized
data management and reporting, 2) clinical trials auditing, 3) statistical support, and 4) administrative and
logistical coordination, across CP-CTNet. In addition, CP-CTNet DMASC will provide an advisory role in early
phase cancer prevention trial development for all CP-CTNet trials and assume the primary statistical role for
supporting cross-network trials.

Public health relevance
Project Narrative Cancer is the leading cause of morbidity and mortality in the US and in the world. The overall goal of the Cancer Prevention Clinical Trials Network (CP-CTNet) is to conduct early phase cancer prevention clinical trials to identify safe and effective preventive agents and interventions that can advance to late phases of clinical development, to ultimately reduce the risk and burden of cancer. Working with the National Cancer Institute’s (NCI’s) Division of Cancer Prevention (DCP), the CP-CTNet Data Management, Auditing, and Statistical Center (DMASC) will support CP-CTNet Sites and coordinate cross-network activities by providing expertise and resources in 1) centralized data management and reporting, 2) clinical trials auditing, 3) statistical support, and 4) administrative and logistical coordination across CP-CTNet.